RANKL regulation of human B cell responses

PROJECT SUMMARY
Improved understanding of B cell biology may uncover therapies that will restore immune tolerance in
autoimmune disease with minimal safety risk. Tumor necrosis factor (TNF) superfamily members are key
regulators of B cell biology, and blockade of several of these pathways has shown significant clinical benefit in
autoimmunity with minimal infectious risk. For example, B cell activating factor (BAFF)-blockade provides benefit
in lupus, a proliferation-inducing ligand (APRIL)-blockade provides benefit in IgA nephropathy, CD40L-blockade
shows promise in Sjogren’s disease, and all these therapies are well-tolerated. TNF superfamily member
receptor activator of NF-κB (RANK), and its ligand RANKL, are highly expressed by memory B cell subsets.
Human genetic variation in RANK is associated with the autoantibody-mediated disease myasthenia gravis. In
mice, transient blockade of RANKL increases the quantity of antigen-specific vaccine titers. Yet, the impact of
RANKL on human humoral immunity remains unknown. Understanding RANK-RANKL B cell control in humans
may identify a new pathway to augment antibody responses to vaccination or dampen autoantibody responses
in autoimmunity with limited safety risk. To address this gap in knowledge, I captured the in vivo human
experiment by collecting plasma and peripheral blood mononuclear cells from individuals receiving denosumab,
an FDA approved RANKL-blocking antibody commonly used in the treatment of osteoporosis, and matched
controls following Covid-19 booster vaccination. I observed a significant increase in Covid-specific IgG
responses, total IgG1, and autoantibody formation to numerous self-antigens in individuals receiving RANKL-
blockade. As RANK signaling can induce FAS in osteoclasts and FAS expression in B cells is a critical negative
regulator of T cell-dependent B cell responses, I hypothesize that blockade of RANKL broadly increases human
B cell responses to vaccination and self-antigen by impairing B cell FAS-mediated apoptosis. This hypothesis
will be tested through the following 3 aims: 1) Determine the impact of RANKL-blockade on humoral and cellular
immunity to recent Covid and influenza vaccination versus remote tetanus vaccination, 2) Define the site of
impaired B cell tolerance and the pattern of autoantibodies following RANKL-blockade, and 3) Test the impact of
RANKL-blockade on FAS-mediated B cell survival in vitro and in vivo. Collectively, these studies will address the
existing knowledge gap of RANKL control of human B cell responses and may provide the foundation to target
RANK-RANKL to tune human humoral immunity.

Public health relevance
PROJECT NARATIVE Tumor necrosis factor (TNF) superfamily members are key regulators of B cell biology, and blockade of several of these pathways has shown significant benefit in autoimmune disease with minimal infectious risk. The TNF superfamily member RANK and its ligand RANKL are highly expressed by B cells, impact B cell responses in mice, and genetic variants in RANK associate with autoimmune disease; yet, RANK-RANKL control of human B cell biology is largely unexplored. By harnessing samples from patients receiving an FDA-approved osteoporosis medication that blocks RANKL, leveraging standard of care vaccination as a lens through which to study B cell responses, and applying cutting-edge techniques to track changes in B cell specificity and function following RANKL-blockade, this work will define the relevance of the RANK-RANKL pathway in human B cells in vivo.